CVD Risk and Outcome Heterogeneity in Older Adults with Diabetes

Project Summary The overall goal of the proposed research is to provide evidence for individualizing care for older adults with prediabetes (PD) and diabetes (DM) by investigating their risks and development of CVD and disability. Older adults with PD and DM suffer disproportionality from diabetes morbidity, particularly CVD and also disability, an outcome that really matters to patients. Our study will use longitudinal data to observe CVD and disability development in PD/DM patients over time. These analyses will lead to practical population based methods to stratify people with DM for their individual risks of CVD and disability, helping to individualize care. Our research will test whether CVD and disability development in PD/DM follows several distinct trajectories with different predictors and risks that will differ by age. We hypothesize that CVD explains the risk of disability more in people with PD/DM < 75 than in those older, and that we can develop risk models to better guide clinical decision-making. The specific aims are to: 1), investigate heterogeneity in the risk of developing CVD In adults from middle to old age aging with PD/DM; 2) investigate heterogeneity in their risk of developing disability; and 3) specify risk models for CVD and disability in people aging with PD/DM, including people with diverse ethnicities and the oldest old. To accomplish our goal we will perform secondary data analysis of the Health and Retirement Survey (HRS) a nationally representative health interview survey that has been collecting data for over 20 years. Besides extensive health interview information, the HRS also features biomarkers (HBA1c, total and HDL cholesterol, CRP, cystatin), physical assessment information (blood pressure, weight, waist circumference, walking speed), prescription medications for a subsample of participants, and Medicare claims linkages. The HRS allows us to evaluate key variables longitudinally, to account for ethnicity and cohort changes in people aging with PD/DM, and to consider management and its changes over many years. The HRS has enrolled nearly 6,000 people with diabetes aged 51 to over 100. We will employ sophisticated statistical analyses as important tools to test our ideas about dynamic processes, time-dependent risks and age-cohort differences. We believe this work will provide evidence to guide individualized DM care for older patients and will will lead to risk models for outcomes that include people of advanced age, diverse ethnicities and complex health status.

Public health relevance
Project Narrative The number of older adults with prediabetes and diabetes is rapidly growing, and they are at increased risk of cardiovascular disease and disability compared to younger people with prediabetes and diabetes. Many studies on diabetes outcomes and management have not included people in their late 70's and older, and have not considered how cardiovascular disease affects disability, making it hard to understand how to manage diabetes in older adults to decrease cardiovascular disease and disability. Our research will study older adults with diabetes including the oldest- old, using data collected over nearly 20 years, to identify how aging with diabetes affects the risks and development of cardiovascular disease and disability, so that we can better individualize treatment for this population.